Genetic Approaches To Characterizing Drug Responses And Vulnerabilities: Mice

There are large individual differences among humans and animals in behavioral, physiological and toxicological responses to drugs of abuse. Many of these individual differences in behavioral responses to drugs display substantial genetic components. Transgenic animals provide means for approaching several interrelated goals: 1)Ascertainment of biochemical and behavioral consequences of the introduction of or disruption of specific genes;2)Ascertainment of the consequences of over- or under-expressing candidate genes identified in human studies;3) Elucidation of gene elements yielding cell-type specific expression and trans-synaptic gene regulation;4) Studying influences of interactions between variants at different genomic loci;5)Elucidating haplotype-specific levels of expression differences in vivo, and 6) allowing us to monitor synaptic connectivities and their modulation by drug administration and alterations in haplotypes in cell adhesion and other impoprtant brain molecules. Interest mechanisms of reward, reinforcement and learning have led to continuing focus on these systems during this year, as we have established much of the groundwork for identification of wiring differences in brain slices. In continuing studies of knockouts of candidate genes that are interesting because they encode drug targets and/or are expressed in circuits of interest, we have reported novel data concerning the differential influences of these knockouts on a) adaptive responses to cocaine (neurotensin KOs) b) stress engendered by social defect (mu/OPRM1 knockouts)c) antidepressants and analgesics (OPRM1 knockouots) d) substance-induced dopamine release (mu/OPRM1 knockouts) e) brain circuitry (DAT/SLC6A3 knockouts) and f) pain responses (DAT/SLC6A4, SERT/SLC6A4 and mu/OPRM1 knockouts). We also aided mouse studies of histamine mechanisms, and supplied knockout mice to many international collaborators. We have initiated studies of the influences of cell adhesion gene alterations by initiating studies of mice with altered expression of the four genes for which our human genome wide association datasests provide the msot consistent replication. We report in abstract form that mice with homozygous or heterozygous deletion of the gene for which we have the strongest evidence in humans, CDH13, dramatically reduce preference for cocaine paired environments. These results display specificity, since cocaine retains locomotor stimulation and since these knockout mice can perform at normal (or supranormal) levels in Morris water maze and other comparison behaviors. Initial data supports the possibility that the magnitude of extinction and reinstatement are also reduced in CDH13 knockouts. These animals thus provide one of the best mouse confirmations of a genome wide association result from a complex, polygenic human locus.